Exploiting a Novel DNA Repair Defect in Ewing Sarcoma

Project Summary
Ewing sarcoma (EwS) is an aggressive subtype of bone and soft tissue cancers in adolescents and young
adults. EwS is recognized as a radiosensitive and chemosensitive cancer. The current 5-year overall
survival for patients with localized disease is 65% to 75%. While the localized disease can be cured by
multimodality treatment in 70% of patients, those with metastatic disease have a poor prognosis with a
5-year overall survival (OS) of less than 30%. Relapsed Ewing sarcoma has an extremely poor prognosis
with a five-year overall survival after relapse of only 10%. Recent studies have identified abnormalities in
DNA Repair (DDR) and Homologous Recombination (HR) in Ewing sarcoma cells. However, the
mechanism by which EWS-FLI1 influences DDR pathways is still largely unknown, and other more
profound DNA repair defects, beyond the HRD phenotype, may exist. Importantly, our laboratory has
surprising new data demonstrating that EwS has an intrinsic defect in Microhomology-Mediated End-
Joining (MMEJ). Previous studies have suggested that EWSR1 is an RNA binding protein with splicing
activity. Our new data demonstrate that loss of EWSR1 results in exon skipping of the POLQ mRNA,
generating a premature termination codon and a profound reduction of POLQ protein expression and
MMEJ activity.As a result, EWSR1 knockout cells showed similar phenotypes to POLQ deficient cells,
including hypersensitivity to topoisomerase inhibitors and irradiation, as well as synthetic lethality with
BRCA1/2 loss. Our new data also show that EWSR1 mutations can disrupt other aspects of MMEJ. For
instance, the fusion protein EWS-FLI1, perhaps through its ability to form condensates, inhibits the
recruitment of POLQ to the DSB loci, resulting in a severe impairment of MMEJ. Our data therefore
indicate that EwS is the only known human cancer that has this unique DDR defect – impaired MMEJ-
activity.We believe this unique DDR defect could be exploited for therapeutic benefit by inhibiting other
DNA repair pathways. Based on our preliminary data, we propose the following three aims: Aim 1 is to
investigate the molecular mechanisms by which the MMEJ pathway is suppressed in EwS. Aim 2 is to
assess the function of the MMEJ pathway in EwS primary tumor tissue from patients.Aim 3 is to exploit
the MMEJ defect for therapeutic benefit in patients with EwS.

Public health relevance
Project Narrative Ewing sarcoma (EwS) is an aggressive subtype of bone and soft tissue cancers in adolescents and young adults which is recognized as a radiosensitive and chemosensitive cancer, suggesting an underlying defect in DNA Repair. The D’Andrea laboratory has recently demonstrated that EwS cells have an intrinsic defect in MMEJ repair. This grant will evaluate the mechanism of this defect and the potential use of novel targeted therapies to exploit the defect.